Coordinated regulation of vascular smooth muscle phenotype by p300, CBP, and TET2

Mature vascular smooth muscle cells (SMC) retain the ability to reversibly dedifferentiate and dramatically alter
their phenotype in response to environmental cues. This plasticity allows for vascular repair and growth, but also
contributes to cardiovascular pathologies including atherosclerosis, intimal hyperplasia, aneurysm, transplant
arteriosclerosis, and others. Little is known about the epigenetic control of SMC phenotypic switching. We have
recently identified TET2 as a novel master epigenetic regulator of SMC phenotype that promotes SMC
differentiation and is downregulated in diseased vessels. TET2 promotes expression of key transcriptional
drivers of SMC differentiation including myocardin and SRF while simultaneously inhibiting expression of KLF4,
a transcription factor associated with dedifferentiation in SMC and pluripotency in stem cells. In addition to its
known function of generating the epigenetic mark 5 hydroxymethylcytosine (5hmC), we have determined that
TET2 also influences histone methylation, indicating that TET2 is involved in global chromatin remodeling in
SMC. Others have shown association between TET2 and HDACs in hematopoietic cells. Our new preliminary
data indicate a physical and functional association between TET2 and histone acetyltransferases (HATs). HATs
acetylate histones in enhancer regions to promote cell type-specific gene expression. We have made the
surprising observation that the HATs p300 and CBP, often considered to be interchangeable, have opposing
roles in regulating SMC gene expression. We find that p300 is required to induce SMC differentiation in culture,
while CBP is required for de-differentiation. Notably, these HATs also oppositely influence 5hmC at contractile
promoters in SMC, and we detect a differentiation-dependent association between p300 and TET2. We
hypothesize that p300 and CBP regulate distinct enhancers at contractile- and synthetic phenotype-specific
genes, respectively, and are critical factors in SMC phenotypic switching. We further propose that TET2/p300
interactions may coordinately regulate chromatin conformation. The overall goal of this proposal is to identify
the mechanisms by which p300, CBP, and TET coordinately regulate SMC phenotypic plasticity. We will
employ state-of-the art molecular biology approaches, animal models, and advanced genomics techniques to
address the central hypothesis that p300 and CBP regulate opposing programs of gene expression by
acetylating distinct cis regulatory elements, and that HATs and TET2 work in concert to remodel chromatin during
SMC phenotype modulation. Aim 1 will determine the mechanistic roles of p300 and CBP in SMC phenotypic
modulation. Aim 2 will aim to define the opposing roles of p300 and CBP on vascular injury response in vivo.
Aim 3 will determine how enhancers are regulated by p300, CBP, and TET2 using deletion approaches in vitro
and in vivo. Collectively, these studies will lead to new understanding of SMC phenotypic modulation, which has
potential for generating new preventive and therapeutic strategies for cardiovascular diseases.

Public health relevance
Project Narrative Vascular smooth muscle cells can change their gene expression and functions dramatically in order to repair and protect blood vessel integrity, but these same protective mechanisms, when unchecked, can also contribute to cardiovascular diseases including atherosclerosis, as well as to failure of revascularization procedures such as angioplasty, stenting, and bypass surgery. We have discovered and will fully characterize new epigenetic mechanisms that regulate widespread changes in SMC gene expression in order to develop better therapies for prevention and treatment of cardiovascular diseases.